A Novel Role of Apical Chloride Transporter (DRA) in Mucosal Tissue Repair

Inflammatory bowel diseases (IBDs) comprising of Crohn’s disease (CD) and ulcerative colitis (UC), are
characterized by chronic inflammation of the GI tract with increasing incidence and prevalence worldwide.
Remarkably, over 66,000 US veterans suffer from IBD and exhibit symptoms such as diarrhea, abdominal
pain and increased gut permeability. Since the IBD pathogenesis is governed by multiple factors, the
treatment is challenging, and repeated relapses occur. Thus, understanding the molecular mechanisms
underlying IBD pathogenesis is critical for developing better therapeutic modalities. Previous studies by the
PI and others have shown that DRA or SLC26A3 (a key colonic chloride transporter) plays a critical role in
IBD pathogenesis. For example, DRA deficiency was shown to increase colonic permeability and alter gut
microbiome. Furthermore, our novel preliminary data from RNA seq analysis and Nanostring nCounter panel
analysis of DRA KO mice colons showed a significant impairment in the expression of genes related to stem
cell lineage, mitochondrial function, ECM organization, cell cycle, and inflammatory response pathways.
Accordingly, DRA KO mice exhibited impaired colonic tissue recovery after acute DSS colitis although
mechanisms are not fully understood. Our preliminary data further demonstrated that DRA KO showed
altered mitochondrial morphology by TEM microscopy, decrease in mucosal ATP levels, an increase in
mitochondrial fission protein (FIS-1) and Cytochrome C protein expression as well as decreased expression
of stem cell markers, LGR5, Hopx and Lrig1 along with decreased b-catenin protein expression. Gut
microbiome manipulation via cohousing of DRA KO mice with WT mice partially restored the altered
expression of stem cell and mitochondrial function markers. However, further studies are needed to
understand the role of DRA in altered mucosal tissue repair via mitochondrial dysfunction and stem cell
dysregulation in the context of intestinal inflammation. Utilizing state-of-the-art approaches including DRA
KO or overexpression mice and appropriate acute and chronic models of colitis, and human and mouse
enteroids, we will test the hypothesis that “loss of DRA results in impaired tissue repair in IBD via
dysregulation of mitochondrial function and stem cell niche” and that strategies restoring DRA
expression can counteract the dysregulation of mitochondrial and stem cell function and impaired
tissue repair. Studies proposed in Aim 1 will examine the mechanisms of DRA in maintaining mitochondrial
and stem cell function in intestinal tissue repair and establish the therapeutic potential of Mito Q and P110.
We will also examine the role of gut microbiome and/or upregulation of DRA expression in maintenance of
mitochondrial function, stem cell niche, and tissue repair upon inflammation injury (Aim 2). The successful
outcome of these studies may aid in identifying novel targets for maintaining longer remission in veterans
with IBD.

Public health relevance
Inflammatory Bowel Disease (IBD) is a common chronic disorder affecting both the general population and our Veterans. Despite all the advancements in the field, IBD repeated flares and relapses occur, and maintaining patients in remission over long periods of time is a major challenge. Thus, there is a dire need to better understand how the disease is developed to improve current treatment options. The proposed research will examine the mechanism by which DRA deficiency in IBD leads to impaired mucosal tissue repair and whether increasing DRA expression by beneficial bioactive dietary lipid (LPA) can restore barrier function and prevent inflammation. This is well aligned with the VA mission to improve the heath care of our veterans.